Evaluating the Relationship Between Age and HIV-1 Persistence

Abstract
Evaluating curative interventions in older people on antiretroviral therapy (ART) is challenging due to the complex
interplay between HIV infection, aging, and age-related comorbidities. We have recently shown in 14 people with
HIV (PWH) receiving long-term ART that there are three patterns of intact proviral DNA decay: 1) a biphasic
decline with markedly slower second phase decline; 2) an initial decline followed by a zero-slope plateau; and
3) an initial decline followed by later increases in intact proviral DNA. In this study, the two participants who had
an increase in intact proviral DNA were females >60 years old and had been on ART for up to 20 years. This
important result raises the question whether age is associated with a slowing decay in intact proviral
DNA among PWH on long-term ART. Accordingly, we will extend these preliminary observations to a large
longitudinal cohort (ACTG A5321) of men and women with a median duration of ART of 14 years (IQR 12 – 17)
(range 5-24 years) and archived blood samples every six months. In addition, cellular senescence is also a factor
that could affect HIV persistence as people age. Senescent cells are in a state of cell-cycle arrest and acquire
the senescence associated secretory phenotype (SASP) resulting in an inflammatory state. If this inflammatory
environment created by SASP leads to proliferation of HIV-infected cells, then senescent cells may play a role
in slowing or reversing the decay of intact proviruses. The central hypothesis of this proposal is that markers
of HIV persistence are more likely to slow their decline, or increase, with age on ART, in association with
increasing markers of immune senescence. To address this hypothesis, we will 1) assess the
longitudinal relationship between age/sex and the levels and trajectory of HIV-1 reservoirs on ART, and
2) determine the longitudinal relationships between the levels and trajectory of HIV persistence markers
and SASP markers. The duration of ART in this ACTG A5321 cohort is much longer than in many other studies
as participants have been in continuous follow-up since initiation of ART and have well-documented virologic
suppression for approximately 20 years with detailed clinical, laboratory, reservoir data and additional blood
samples from immediately pre-ART through the present day. We will evaluate 100 A5321 participants over
multiple timepoints for levels of intact proviral DNA, total DNA, residual HIV-1 RNA using the single copy assay
and assess the relationships between levels of these persistence markers and age/sex. In a subset of 25
participants, we will perform bulk integration site analysis to determine the clonality of cells carrying proviruses
as a function of age. We will also measure a panel of SASP markers using a multiplex platform using samples
from the 100 participants in Aim 1 to assess whether the measures of HIV persistence in Aim 1 are associated
with the markers of senescence.

Public health relevance
PROJECT NARRATIVE It is important to study how aging and cellular senescence affect persistence of the HIV reservoir to inform strategies to cure HIV-1 infection. Preliminary observations made by our group suggest that age is a key determinant of reservoir dynamics on long-term ART. In the current proposal, we will leverage a rich repository of stored blood samples and extensive clinical data from the AIDS Clinical Trials Group A5321 cohort, a longitudinal cohort of individuals who have had viremia suppression on ART for an average of 14 years (IQR 12- 17 years), to determine whether the dynamics of the HIV reservoir are associated with age, sex, and levels of cellular senescence markers in blood.